Core 1: FACILITIES MAINTENANCE AND OPERATION

Core 1: Facility Maintenance and Operation
Abstract
The NEIDL Facilities Maintenance and Operations (FMO) Core is comprised of three functional areas:
Facilities, Information Technology and Community Relations. Each is tasked with closely related but distinct
responsibilities that collectively maintain the function, safety, and community understanding of the NEIDL BSL-
4 and ABSL-4 operations. Facilities (FAC) provides in-house biocontainment facility operations and
management expertise in support of BSL-4 research and regulatory compliance; and continues to advance
BSL-4 operations through training of staff, performing risk assessment-based repair and maintenance
activities, improving SOP’s, future planning for infrastructure needs and technology advancements, and
managing regulatory compliance of biocontainment performance requirements. Partners with EH&S, IT, Public
Safety and Research Cores to meet overarching NEIDL goals and progressively expand efficiencies and
effectiveness over the next 5 years and beyond. Information Technology (IT) supports BSL-4 research by
developing and deploying state-of-the-art technology solutions and training to BSL-4 researchers and staff,
such as “in-suit” hands-free communications systems, video-enhanced SOPs for in-lab training and use,
dedicated instrumentation computing resources and mobile applications for BSL-4 laboratory use. The next
five years of technology advances will focus on testing and implementing multiple IT systems for BSL-4
science. The Community Relations (CR) Unit builds and nurtures relationships with the community by
engaging Community Liaison Committee to build engagement programs that build trust and mutual respect
with our community. Traditional forms of engagement like hosting NEIDL facility tours, panel discussions, and
hands-on educational programs will be adapted in response to the new challenges and health risks posed by
the global COVID-19 pandemic.